Understanding how cells invade through basement membrane in vivo

PROJECT SUMMARY
Basement membrane (BM) is a dense, sheet-like extracellular matrix that surrounds most tissues. During
development and immune cell trafficking, specialized cells acquire the unique ability to breach BM barriers to
disperse, construct tissues, and migrate to sites of infection and injury. Cell invasion is also inappropriately
initiated during numerous diseases and underlies tissue destruction in asthma, stroke, arthritis, multiple
sclerosis, and metastatic cancer. Understanding how cells traverse BM barriers is thus of fundamental
importance in improving human health. Cell invasion events are often stochastic, rapid, and involve dynamic
adhesions and communication between the invading cell, the BM, and the neighboring tissues. Owing to this
complexity, it is not possible to faithfully recapitulate cell invasion with in vitro assays, and it has been difficult
to visualize and genetically dissect invasion in vertebrate tissues. As a result, the mechanisms underlying cell
invasive behavior remain poorly understood. Anchor cell invasion in C. elegans is a highly stereotyped in vivo
model of cell invasion that uniquely combines many powerful experimental approaches including subcellular
visual analysis of cell-BM interactions, molecular activity sensors, rapid genome editing, cell-type specific gene
manipulation, and powerful forward genetic and functional genomic approaches. Using these strengths, this
study will characterize how invading cells acquire and use energy to fuel BM invasion. This work will reveal
mechanisms that direct polarized glucose import and the construction of specialized electron transport chain
enriched mitochondria that provide localized ATP to power the BM breaching machinery. Further, the outlined
experiments will determine how lipid biosynthesis is integrated into a conserved cell invasion transcriptional
program and how lipid producing enzymes, which are overexpressed in most metastatic cancers, build a large,
transient, invasive protrusion that opens paths through BM barriers. The proposed study will also elucidate how
invasive cells adapt their invasion program to the absence of matrix metalloproteinases (MMPs) by physically
displacing the BM, which will inform more effective approaches to block invasion with MMP inhibitors that have
thus far failed to be effective in clinical trials. Finally, this work will identify molecular mechanisms that prevent
and heal plasma membrane damage during BM breaching, thus revealing mechanisms that could be exploited
to target cells in the act of invading. These integrative studies spanning cellular energetics, extracellular matrix,
transcriptional regulation, and membrane dynamics are relevant to the NIH’s mission as they will lead to a
deeper understanding of the fundamental biological process of cell invasive behavior, thus allowing for the
development of better therapeutic strategies to modulate invasion in human disease.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Cell invasion through basement membrane barriers is crucial for tissue formation during development and immune cell trafficking to reach sites of infection. Cell invasion is also inappropriately co-opted in many human diseases including immune disorders and cancer. The proposed work will reveal how invasive cells acquire and use energy, build invasive structures, and withstand the stress of breaching basement membranes, which will advance our understanding of the mechanisms underlying cell invasion and generate new therapeutic strategies to modulate this behavior in developmental disorders and other human diseases.